2024 Centromere Biology Gordon Research Conference

Project Summary/Abstract
Centromeres remain perhaps the most enigmatic regions of the genome, even though they provide the
foundation for chromosome segregation during every eukaryotic cell division. Despite the “complete sequencing”
of the human genome more than a decade ago, it was only recently that the first assembly of a human centromere
was completed. In addition, due to the highly repetitive nature of the centromere sequences in humans and most
other organisms, data from centromeres is excluded from almost all genome-wide studies that typically require
sequencing reads to map to a single locus. If we are to truly understand the genome, it is critical to address this
important gap in our understanding to reveal the nature of centromeres. Breaking through these challenges
requires a unique conceptual framework and set of tools and technologies that combine genome technologies
(such as longer sequencing read lengths), computational and bioinformatics approaches, and together with
complementary functional biological studies.
The goal of the Centromere Biology conference is to substantially advance our understanding of the centromere
regions of each chromosome by convening researchers of diverse disciplines focusing on this genomic locus.
This meeting will bring together a diverse group of outstanding scientists to build a community interested in
understanding diverse aspects of centromere properties including the sequence, nature, organization, evolution
(including sequence diversity across the human population), and function of this incredibly important and unique
genomic locus. Speakers will represent the diversity of disciplines that this community attracts including
genomics, bioinformatics, genetics, epigenetics, biochemistry, biophysics, structural biology, cell and molecular
biology, as well as theory and modeling. We value this meeting as part of a larger effort to build an inclusive and
diverse the centromere community, including strong representation from women and early career researchers.

Public health relevance
Project Narrative The goal of the Centromere Biology conference is to substantially advance our understanding of the centromere regions of each chromosome by convening researchers from diverse disciplines focusing on this genomic locus. This meeting will bring together outstanding scientists interested in understanding different aspects of centromere properties including the sequence, nature, organization, evolution (including sequence diversity across the human population), and function of this important and unique genomic locus. This meeting will also strive to build an inclusive and diverse centromere community.